The role of Ly49 family of receptors on CD8 T cells

PROJECT SUMMARY/ABSTRACT
We have shown that Ly49 family of surface receptors mark CD8 Tregs in mice. Ly49 refers to a family of
receptors for MHC class I that is primarily expressed by natural killer (NK) cells. A subset of CD8 T cells express
inhibitory Ly49 family members, which contain immunoreceptor tyrosine-based inhibitory motifs (ITIMs) in their
cytoplasmic domains. Beyond their utility as markers of CD8 Tregs, however, the functional contribution of these
Ly49 receptors to CD8 Tregs has not been investigated. Ly49+ CD8 T cells have long been known to be highly
responsive to IL-15, but the role of IL-15 in the function of CD8 Tregs is also not known. It has also been argued
that the transcription factor Helios is needed for CD8 Treg function. Yet experiments to date have not clearly
distinguished the role of Helios in the development of CD8 Tregs from the ongoing need for Helios while CD8
Tregs perform their regulatory functions. Integrating our results and these outstanding questions, our central
hypothesis is that immunization expands the sub-population of CD8 Tregs that can resolve a given immune
response, and Ly49 and Helios are required for the development and function of these CD8 Tregs. The relevance
of these questions for human health and disease was made clear by our recent study from us of the human
counterpart to Ly49+ CD8 Tregs. In our recent study, we show that KIR+ CD8 T cells were elevated in the blood
of celiac disease patients and individuals with several other autoimmune diseases. Our study thus argued that
KIR+ CD8 T cells function to suppress self-reactive CD4 T cells and are transcriptionally and phenotypically
equivalent to mouse Ly49+ CD8 Tregs. Therefore, a better understanding of the determinants of Ly49+ CD8
Treg function may therefore apply to an important population of human regulatory T cells. The efforts undertaken
in this project could help to inform future approaches to harness KIR+ CD8 Tregs for the treatment of autoimmune
diseases in human patients.

Public health relevance
PROJECT NARRATIVE The main objective of this application is to better understand the determinants of Ly49+ CD8 Treg function which may apply to an important population of human regulatory CD8 T cells. The efforts undertaken in this project could help to inform future approaches to harness KIR+ CD8 Tregs for the treatment of autoimmune diseases in human patients.